CytoFLEX LX flow cytometer

Project Summary: Acquisition of a CytoFLEX LX Flow Cytometer
The Integrated Imaging Center (IIC) at Johns Hopkins University is applying to purchase a
Beckman Coulter CytoFLEX LX flow cytometer to replace an existing BD FACSCalibur instrument.
The existing instrument has reached the end of its service life. The CytoFLEX has a number of
major upgrades allowing significantly more experimental modalities to be used. These include
more lasers, many more analysis parameters, small particle size measurements with a side
scatter detector, absolute concentration measurements and the option of a multi-well plate
compatible autoloader. This instrument will be used for a range of ongoing research projects
including work on kinetically assembled nanoparticles for mRNA delivery in cancer treatment,
the study of Alzheimer disease progression, the characterization of photoreceptor development
pathways, how DNA replication influences epigenomics in stem cells and the use of nucleic acid
nanotubes to treat primary and metastatic tumors.
These projects will directly benefit from the expansion of the number of parameters available
for analysis, allow many more signals to be simultaneously measured, and much better data on
complex interaction between multiple components. This will generate equivalent or better data
from many fewer experiments, when many components are involved. By having more laser
sources, we will have more flexibility in dye choices and the ability to truly use the high
parameter analysis possible on this machine. The addition of a 96-well plate auto-loader will
allow much higher throughput of samples and dramatically reduce preparation time as many
experimental workflows already use 96 well plates for sample preparation, enabling these
plates to be simply loaded into the flow cytometer rather than transferred into tubes for
analysis.
Overall, this instrument will enable a range of new experiments and increase the productivity of
existing experimental workflows. This will increase our basic understanding of a range of
cellular processes and help speed the translation of emerging therapeutics from the lab to the
clinic.

Public health relevance
Project Narrative: The purchase of this instrument will allow a number of research groups at Johns Hopkins University to accelerate the development of novel cancer treatments, improving the outcome for future cancer suffers. It will also be used to better understand basic biological processes involved in human eye development and in stem cell division, which in the longer term will help us understand a range of human eye disorders and more general developmental conditions.